SESORRS endoscopy for the staging and evaluation of colorectal cancer

PROJECT SUMMARY/ABSTRACT:
Colorectal cancer (CRC) is the third most common cancer and a leading cause of death worldwide. The degree
of CRC invasion into the large intestinal wall is associated with patient prognosis. White light endoscopy (WLE)
is used to evaluate lesions of interest within the colon, however WLE provides only morphological information,
often failing to efficiently evaluate the required resection margin or extent of tumor invasion. There is a significant
need to develop an endoscopic approach that can address these challenges. We believe this could be achieved
using spatially offset Raman spectroscopy (SORS) in combination with surface enhanced resonance Raman
scattering (SERRS) contrast agents (CAs). The combination of the two approaches is referred to as surface
enhanced spatially offset resonance Raman spectroscopy (SESORRS). In the proposed preclinical study, I will
test the hypothesis that SESORRS endoscopy could improve existing practices for the detection, staging and
surgical resection of CRC. During the K99 mentored phase, I will build and validate the efficiency of a SORS
endoscope using ex vivo phantoms (SA1.1, SA1.2). Using Apcfl/+ and Apcfl/+;KrasG12D/+ mouse models of CRC,
we will evaluate the efficiency of SESORRS endoscopy to detect and stage CRC in vivo. Results will be
correlated with MRI, PET, and ex vivo histology (SA2.1). The biodistribution and pharmacokinetic profiles of
radiolabeled SERRS CAs will be evaluated using PET imaging (SA2.2). As an independent investigator, I will
determine the optimal dose of SERRS CAs required for SORS endoscopic imaging of CRC (SA2.3). In SA3 I
will determine and validate the advantage of using molecularly targeted-SERRS CAs over non-targeted SERRS
CAs, together with the ability of SESORRS endoscopy to assist in the surgical resection of lesions of interest by
detecting residual tumor cells on the surface, and beneath, the resection bed. If successful, SESORRS
endoscopy could be very useful in the screening, diagnosis, and treatment of CRC. This project will enable us
to predict the potential success of clinical SESORRS endoscopy and increase the likelihood of achieving
eventual clinical translation. I have a unique set of expertise in SERRS, SORS and SESORRS imaging and
believe I am highly qualified to lead, and conduct, the proposed project here at the Dana-Farber Cancer Institute.
I also have identified the following key areas which require additional training in order to support my transition to
independence: (1) mouse models of CRC; (2) understanding the cancer biology of CRC and the influence of
genetic mutations on CRC invasion; (3) radiochemistry and PET imaging and; (4) requirements for clinical
translation. I have deliberately chosen and carefully assembled a world-class committee of mentors and advisors
including my primary mentor Dr. Kevin Haigis, as well as Dr. Conor L. Evans and Dr. Norman Nishioka who will
serve as co-mentors. My mentors are in full support of my research and career goals. I am committed to this
award and strongly believe that it will help me gain the necessary training required to enable my long-term career
goal of being an established investigator in the field of molecular imaging.

Public health relevance
PROJECT NARRATIVE This proposal focuses on the development of a novel surface enhanced spatially offset resonance Raman spectroscopy (SESORRS) endoscope for the imaging and evaluation of colorectal cancer (CRC). Current clinical practices for the endoscopic imaging of CRC provide only morphological information, often failing to efficiently evaluate the required circumferential resection margin, or extent of tumor invasion into the wall of the colon. We aim to show that it is possible to use SESORRS endoscopy to determine the true extent of tumor invasion in real time, and use SESORRS endoscopy to support the image guided resection of lesions of interest by detecting residual tumor cells on, and beneath, the surface of the resection bed.